Detection and quantification of amyloidosis deposition and circulating amyloid fibrils in asymptomatic carriers of the V122I TTR allele

PROJECT SUMMARY
Virtually exclusive to individuals of African ancestry, the valine-to-isoleucine substitution at position 122 (V122I)
variant in the transthyretin (TTR) protein is the most common cause of hereditary cardiac amyloidosis (ATTR-
CA) worldwide. ATTR-CA causes progressive heart failure (HF) and has no proven benefit from standard HF
treatments. Fortunately, new therapies that stabilize TTR improve morbidity and mortality in ATTR-CA, especially
when prescribed early in the disease. However, early diagnosis is uncommon and conventional diagnostic tools
lack diagnostic specificity to detect early disease. As such, a screening technique that directly assesses amyloid
infiltration, without the need for cardiac biopsy, in V122I TTR carriers is a major unmet need. Thus, the objectives
of this proposal are to determine the presence of amyloid in the blood by measuring circulating TTR amyloid
aggregates (TAAs) and the presence of early cardiac amyloid infiltration with iodine-124 evuzamitide (I-124E)
positron emission tomography (PET) imaging. The central hypothesis of this proposal is that V122I TTR carriers
will have detectable blood and imaging evidence of ATTR-CA prior to disease onset. Two specific aims will test
this hypothesis: Aim 1) determine the association of V122I TTR carrier status with circulating TAAs; Sub-aim
1.1) determine the association of TTR stabilizing therapy with circulating TAAs over time in patients with ATTR-
CA; Sub-aim 1.2) Determine the association of circulating TTR amyloid aggregates with structural and functional
evidence of amyloid infiltration and cardiac reserve; Aim 2) determine the association of V122I TTR carrier status
with direct evidence of cardiac amyloid infiltration by I-124E; and Sub-aim 2.1) determine the association of
circulating evidence of TTR amyloidosis with the amount of cardiac amyloid infiltration. All aims will leverage
active investigation of a large cohort of V122I TTR carriers who have undergone deep clinical, imaging, and
biomarker phenotyping (NCT05489549). In Aim 1, TAA levels will be measured and compared in a cohort of
V122I TTR carriers without HF, non-carrier controls, and subjects with symptomatic ATTR-CA. Sub-aims 1.1
and 1.2 are substudies that will determine the longitudinal stability of TAA levels as well as their association with
TTR-stabilizing treatment and evaluate the association of TAA levels with early pathophysiological evidence of
cardiac amyloidosis by CMRI, respectively. In Aim 2, I-124E PET imaging will be used to measure and compare
early cardiac amyloid infiltration in V122I TTR carriers, race-matched controls, and subjects with symptomatic
ATTR-CA. Sub-aim 2 will evaluate the association of TAA levels with cardiac amyloid infiltration by I-124E PET.
The research proposed is innovative, because it will, for the first time, employ two highly sensitive and specific
techniques to detect and quantify amyloidosis in V122I TTR carriers: 1) detection of circulating TAAs by structure-
based probes and 2) PET imaging with I-124E, a novel amyloid-binding peptide. Identifying amyloidosis prior to
ATTR-CA disease onset will allow us to track the natural history of the disease and justify age-based screening
strategies leading to reduced HF morbidity and mortality through earlier ATTR-CA recognition and treatment.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will address the fundamental question of whether amyloidosis is present in V122I TTR carriers and provide a strong scientific justification to develop screening and to test preventive treatment strategies for subclinical hereditary ATTR-CA. Key findings from this proposal will change how we think about this disease and will justify future research towards reducing heart failure morbidity and mortality by way of earlier ATTR-CA recognition and earlier treatment. Thus, the proposed research is relevant to part of the NHLBI’s mission to promote the prevention and treatment of heart disease.